Directed Cell Motility Along Gradients in Extracellular Matrix Fiber Alignment

Project Summary
In native tissue, cell recruitment and positioning are controlled by directed migration, where cells sense
multiple guidance cues in their microenvironment and migrate preferentially toward or away from particular
signals. Although several types of guidance or "taxis" cues have been identified, the hierarchy between
simultaneously presented signals during directed migration remains poorly understood. Dissecting these
relationships will help enhance our understanding of cell motility in complex environments with broad
implications in therapeutic development to promote or inhibit migratory activity.
To expand our knowledge about the cues that promote directed cell migration, we propose a new experimental
platform that combines microengineered fiber alignment gradients with controlled soluble biochemical
gradients to endothelial, immune, and cancer cell migration within a complex 3D environment. Our platform
will allow us to uniquely expose cell populations to a controlled multi-cue 3D environment containing alignment
gradients and biochemical gradients to dissect how cells prioritize and respond to simultaneous guidance
cues. We hypothesize synergetic (additive) and hierarchal (competitive) relationships between biophysical and
biochemical guidance cues that influence directed cell migration. To test this hypothesis, we will carry out the
following aims: 1) Quantify migration within a microengineered 3D collagen gel environment with tunable
alignment landscapes, 2) Create biochemical gradients and quantify chemotactic responses within 3D gel
environments, and 3) Quantify motility responses within combined biophysical and biochemical gradient
environments.
Success in this project will establish a platform to uniquely study how cells sense, prioritize, and migrate in
response to multiple guidance cues (here, biophysical and biochemical gradients), with relevance to early
development, immune cell trafficking, vascularization, and cancer invasion.

Public health relevance
Project Narrative To expand our knowledge about the cues that promote directed cell migration, we propose a new experimental platform that combines aligned collagen fiber landscapes with soluble biochemical gradients to study directed migration within a complex 3D environment. If successful, our platform will dissect how different cell populations prioritize and respond to simultaneous guidance cues with relevance to early development, immune cell trafficking, vascularization, and cancer invasion.